The role of Abelson interactor 1 (Abi-1) in hematopoietic stem cell self-renewal and malignant transformation

PROJECT SUMMARY/ABSTRACT
It is well established that JAK/STAT signaling is dysregulated in most myeloid malignancies. Identification of
JAK-activating mutations in myeloproliferative neoplasms (MPNs) prompted the development of inhibitors that
target JAK for use in the clinical setting. While these agents provide a symptomatic response, they do not alter
the underlying disease in that they do not target MPN-initiating malignant hematopoietic stem/progenitor cells
(HSPCs). This observation has been interpreted as indicating that alternative signaling pathways contribute to
the pathogenesis of MPNs. The present proposal is based on the premise that identification of hitherto
unknown pathogenic mechanisms will be required to effectively treat these neoplasms and eradicate disease
initiating MPN stem cells. Our long-term goal is to define signal transduction events responsible for systemic
maintenance of HSPCs, with particular focus on key adapter proteins that modulate signals regulating HSPCs
self-renewal, differentiation and their malignant transformation. Our direct objective is to elucidate the role of
one such adapter protein, Abelson interactor-1 (Abi-1), in signaling cascades that define the HSPC phenotype.
Our recent findings indicate that: (1) conditional deletion of the Abi1 gene in mouse bone marrow induces a
myelofibrotic phenotype; (2) hematopoietic progenitors and granulocytes from patients with the most severe of
MPNs - primary myelofibrosis (PMF) show decreased Abi-1 transcript and protein levels, and; (3) loss of Abi-1
positively affects the activity of Src Family Kinases (SFKs) and their downstream signaling to STAT3 and NF-
κB, resulting in impairment of HSPC self-renewal and fitness. Our central hypothesis is that Abi-1 plays
an important and potentially targetable role in HSPC self-renewal and differentiation via negative regulation of
the SFK/STAT3/NF-κB inflammatory module, and that its acquired absence can promote malignant
transformation and progression to PMF. Our central hypothesis will be tested in the following three Specific
Aims. In Specific Aim 1 we will use our new hematopoietic cell-specific Abi-1 knockout mouse model to
determine the effect of Abi-1 loss on HSPC signaling and self-renewal, differentiation and malignant
transformation. In Specific Aim 2, we will use advanced proteomics combined with proximity-dependent
labelling technology to define the Abi-1 interactome in HSPCs. This approach will be complemented by
phosphoproteomic analyses of Abi-1-deficient HSPCs and human PMF stem/progenitor cells. In Specific Aim
3 we will use our bone marrow stroma-specific Abi-1 knockout mouse model to assess the effect of deletion of
Abi-1 in the stromal component on the self-renewal, differentiation and malignant transformation of HSPCs.
Completion of the proposed aims will advance our understanding of the mechanisms by which dysregulation of
Abi-1/SFK/STAT3/NF-kB signaling contributes to the neoplasm-inducing capacities of HSPCs. This new
knowledge will be used to make progress toward our long-term translational goal of identifying therapeutic
strategies that target cells responsible for the origin of myeloproliferative neoplasms.

Public health relevance
PROJECT NARRATIVE/RELEVANCE The JAK/STAT cascade is dysregulated in nearly all myeloproliferative neoplasms (MPNs), including most severe of MPNs – primary myelofibrosis (PMF), however, currently available inhibitors that target the JAK/STAT pathway are not able to eradicate disease-initiating malignant hematopoietic stem cells. The objective of this research plan is to determine the role of newly identified Abelson interactor 1 (Abi-1)-driven mechanisms responsible for malignant transformation of hematopoietic stem cells and initiation of PMF. Our ultimate goal is to develop new therapeutic strategies to eradicate disease initiating PMF stem cells.